Effectiveness of Out-of-Pocket Cost COMmunication and Financial Navigation (CostCOM) in Cancer Patients

PROJECT SUMMARY
High out-of-pocket costs (OOPC) of cancer treatment and lost income result in financial hardship. There is
compelling evidence that OOPC communication complemented by financial navigation and counseling will
decrease financial hardship by enabling cancer patients to anticipate and accommodate treatment costs and
proactively seek financial assistance. Importantly, this intervention aligns with the Centers for Medicare and
Medicaid Services (CMS) price transparency mandate. We will evaluate the effectiveness of an innovative
personalized intervention designed to improve cost-related cancer care non-adherence by conducting a
randomized controlled trial of OOP cost communication and financial navigation (CostCOM) vs.
enhanced usual care (EUC) at NCI Community Oncology Research Program (NCORP) practices. Our
multidisciplinary team has experience with all facets of the proposed intervention including conducting clinical
trials at NCORP practices. CostCOM comprises four 1-hour counseling sessions to impart: (1) OOPC
communication, individualized, patient-specific education of the anticipated OOPC using a price estimator tool;
(2) Financial navigation, real-time professional guidance to identify financial assistance programs that will
alleviate costs of care and discuss information to improve insurance coverage; and (3) Financial counseling to
address the range of patients’ financial concerns and enroll patients in financial assistance programs. We will
recruit 720 patients with newly diagnosed solid tumors (1:1 non-metastatic vs. metastatic) who plan to receive
anticancer therapy at one of the participating NCORP practices. CostCOM arm patients will participate in four
phone or video sessions with a remote financial counselor at baseline, 3, 6, and 12 months, with all three
components of CostCOM delivered at each session. At enrollment, EUC arm patients will receive usual care
enhanced by providing an educational brochure describing services and contact information of the Patient
Advocate Foundation (PAF), a national non-profit financial navigation organization. Patients will complete
surveys at baseline, 3, 6, and 12 months after enrollment. Our goals are to (1) compare the effectiveness of
CostCOM vs. EUC at 12 months on patient-reported cost-related cancer care nonadherence, defined as any
self-reported incident of delay, forgo, stop or change in cancer care due to cost concerns, as well as (2)
patient-reported material financial hardship, financial worry, and quality of life; and (3) conduct a process
evaluation to examine practice providers and CostCOM arm patients’ satisfaction with the intervention and
their perceptions of barriers and facilitators to CostCOM delivery (for providers) or receipt (for patients). A
successful CostCOM is a scalable and financially sustainable program that can be disseminated across
systems, conditions, and populations and improve cancer care delivery, patients’ experience, and health
outcomes.

Public health relevance
PROJECT NARRATIVE Most cancer patients experience financial hardship as a direct result of receiving expensive cancer care and lost income. Our study will test the effectiveness of a multicomponent financial counseling program, CostCOM, that will help patients with newly diagnosed cancer at NCI community oncology research program (NCORP) practices across the United State to learn about their personalized treatment out-of-pocket costs using a price estimator tool, understand their insurance benefits, and receive financial navigation (e.g., get enrolled in financial assistance programs). We anticipate that CostCOM compared to enhanced usual care will improve cost-related cancer care nonadherence and quality of life and decrease material financial hardship and financial worry.